Administrative Core

Project Summary/Abstract - Administrative Core
The overarching goal of the Administrative Core is to lead, manage, and harmonize all aspects of the
IU O’Brien U54 National Resource Center (NRC) and ensure that that the IU O’Brien resources are
shared nationally. This goal will be accomplished through collaboration with the U24 O’Brien National
Coordinating Center (NCC) to: 1) Prioritize external requests from the kidney research community for the
efficient utilization of the two IU O’Brien Biomedical Resource Core (BRC) resources consisting of the Intravital
Microscopy BRC and the Molecular Imaging BRC; 2) engage in activities to enhance national outreach and
impact of the IU O’Brien NRC; 3) educate the community about kidney research; 4) monitor and evaluate
emerging advances in imaging science in conjunction with the IU O’Brien Resource Development Core; 5)
asses imminent research needs of the kidney research community; 6) organize a broad range of educational
programs to provide a pipeline of future kidney researchers, assist early stage investigators, and attract new
investigators from outside the kidney research community; and 7) develop pathways that enhance the diversity
of the kidney research community. The Administrative Core will serve as the portal for communication and
coordination with the O’Brien U24 NCC, other U54 O’Brien NRCs in the consortium, and the kidney research
community at large. The IU O’Brien Resource Center will provide a unique and powerful service to the kidney
research community. Together, the assets of the two IU O’Brien BRCs and the Resource Development Core
coordinated by the Administrative Core will allow investigators in the kidney research community to test and
refine key hypotheses as they pertain to a vast array of kidney diseases. Therefore, the proposed research
service is significant, because it is expected to aid the kidney research community in identifying critically
needed biomarkers of disease progression, optimizing preclinical studies, and developing specific and targeted
therapeutic interventions for a wide range of kidney diseases.